Impact of a Maryland Law Requiring Jails to Provide Medications for Opioid Use Disorder on Recently Incarcerated People.

ABSTRACT
People with opioid use disorder are often forced to undergo withdrawal during incarceration due to lack of
opioid treatment in custody, contributing to their elevated risk of drug overdose and other negative health
outcomes in the weeks after release. Providing access to medications for opioid use disorder (MOUD) in
correctional settings is a promising strategy to reduce overdose risk, but jails have not widely adopted this
strategy. Achieving maximal public health benefits will require that MOUD programs are adopted across local
jails that vary substantially in their resources and capacity, that benefits diffuse widely across racial/ethnic
groups, and that jails ensure transition to treatment providers in the surrounding community after release. In
2019, the Maryland legislature passed the first U.S. law requiring all local jails in the state to provide all forms
of MOUD and create linkages to care after release. The legislation created a phased implementation of the
program starting in 2020. The staggered implementation presents a natural experiment to evaluate how the
implementation of the programs in jails affect a variety of post-incarceration outcomes overall, and across
different facilities and local environments. We propose a mixed-methods evaluation of the Maryland law. Aims
1 and 2 will analyze a data warehouse that links statewide correctional records, hospital, prescription
monitoring program, behavioral health, and medical examiner data. Aim 1 will consider overall impacts of
exposure to the jail MOUD program using non-experimental methods that compare changes in post-release
outcome before and after jails implement the program. Aim 1B will use implementation measures reported to
the state to assess whether outcomes differ in jails with high versus low levels of implementation based on
monthly reports of program participation. Aim 2 will examine racial/ethnic disparities in the impact of the policy,
and assess the contribution of variables at the individual, jail, and community level (e.g., social stressors,
access to treatment) on inequitable outcomes. We hypothesize that overdose and other hospitalizations will
decrease and MOUD use will improve among individuals leaving facilities with MOUD programs. We also
hypothesize that impacts will be strongest for people treated at programs with high (versus low) levels of
implementation. We hypothesize that people from minoritized backgrounds will not gain as much from the
policy as non-Hispanic white people due to pervasive inequities in access to resources in jails and post-
release. Aim 3 will provide complementary implementation evidence focusing on 8 jails. We will conduct in-
depth, semi-structured interviews with 40 program leaders (e.g., jail staff, community providers) and 40
formerly incarcerated individuals to explore barriers and facilitators to providing MOUD in jail and post-release.
Together, study Aims will provide new evidence about how statewide jail initiatives may increase MOUD and
improve health among people leaving jails. This information can guide future efforts in jails in Maryland and
other states as they adopt MOUD treatment programs and adapt these programs to their local environments.

Public health relevance
PROJECT NARRATIVE Increasing access to medications for opioid use disorder could dramatically reduce risk of overdose and other negative health outcomes after release from jail, but these medications are often not available during and after jail stays. In this project, we study the public health impact of a statewide law in Maryland requiring local jails to provide access to medication during incarceration with linkage to care after release.